NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens

Project Summary/Abstract
The Tennessee Department of Health (TDH) is a long-term participant and leader in the
National Antimicrobial Resistance Monitoring System (NARMS) Retail Food
Surveillance (RFS) program. TDH feels that the expansion of the retail food arm of
NARMS is a critical step in conducting surveillance for antimicrobial resistance (AMR) in
the food chain and for monitoring the impact of recent national initiatives, including
important regulatory changes in the use of antimicrobials in food animals. Use of
antimicrobials in food animal production creates selective pressure that enables
antimicrobial-resistant bacteria to migrate to the food supply and ultimately cause
human infections. Of concern, antibiotic-resistant infections are accompanied by more
severe illnesses, more deaths, higher healthcare costs, and increased harm to society.
We feel that surveillance is critical “data-for-action” to not only understand the sources
of AMR and multidrug resistance (MDR) in the food supply chain but to combat this
public health problem. Tennessee embraces the goal of the NARMS food surveillance
program to improve the detection of and surveillance for AMR among enteric bacteria in
raw retail food commodities through this cooperative funding agreement (FOA # PAR-
25-014). Tennessee will participate fully in all project components, including the
purchase of approved meats and seafood, testing by NARMS protocols, shipment of
isolates and metadata, and continued activity in the NARMS working groups.
Additionally, Tennessee anticipates participating in any future pilot activity or expansion
to other commodities. Tennessee's capacity for testing food has translated to increased
ability to assess isolates and their link to human clusters, as well as more proficiency in
testing food during outbreaks and quickly characterizing the AMR properties to inform
the public health investigation. Tennessee will participate fully in all NARMS RFS
activities and follow the accepted protocols during the 5-year period. Our strategy
includes: 1. Maintain sampling and reporting with a continuous quality improvement
paradigm in RFS. 2. Foster partnership among Tennessee, federal, state, local, and
external partners. 3. Enhance outbreak investigation response and reporting. 4. Sustain
and enhance NARMS laboratory diagnostic capacity. 6. Improve laboratory
coordination, outreach, and information flow. 7. Maintain and exchange the integrated
surveillance information system. Tennessee’s expectations and outcomes, strategies
and activities, and collaborative activities will continue throughout the 5-year period with
continued funding. We hope our response to this FOA will be favorably considered.

Public health relevance
Project Narrative AMR is a complex emerging issue involving humans, animals, and the environment. A comprehensive approach must address all aspects, including AMR of human infections, in food animals, and in retail meat. Tennessee has participated in the NARMS RFS for more than two decades through multiple funding mechanisms (CDC ELC and FDA funding). Tennessee has proven performance and desires to partner with the FDA and other RFS sites to enhance and expand the program. We hope that our response to this FOA will be favorably considered.